The gEAR portal - Advancing Data Sharing, Analysis and Discovery for Hearing and Balance Research

ABSTRACT
Discovery in biological sciences has shifted to increasingly rely on high throughput multi-omic data. The
advent of single cell (sc) transcriptomics further revolutionized research in our field, given the intricate structure
of the inner ear organs consisting of numerous distinct cell types that function in concert to properly sense
hearing and balance. Harnessing the wealth of existing and future multi-omic, multi-modality and multi-species
data is challenged by their ever-increasing data size and relative inaccessibility to biologists that are not trained
in bioinformatics. The gEAR, gene Expression Analysis Resources (umgear.org), is a cloud-based `one-stop-
shop' where inner ear-related multi-omic data can be explored and analyzed by biologists without requiring
programming skills. Over the past five years, the gEAR has become a critically valuable resource to our field.
The impact of the gEAR on the field is reflected by its 846 registered users, 440 datasets (over 70 organized in
thematic profiles in the public domain), and thousands of monthly visits.
The goal of this proposal is to implement necessary improvements in the gEAR that will significantly
enhance the ability of researchers to infer biological insights from the omics data generated by their own
laboratories and from omics datasets in the public domain. We will: (1) continuously upload and curate ear-
related multi-omic data from contributing laboratories and the public domain; (2) construct an integrated
epigenetic and transcriptomic atlas of the developing and mature mouse cochlea (a) as a necessary scaffold
for cross dataset integration, and (b) as necessary data for bridging the gap between gene expression and
gene regulation; (3) implement advanced bioinformatic analytical tools in the gEAR; (4) enhance the user-
interface; (5) make scalability, performance and stability improvements; (6) integrate the gEAR with analytical
notebooks to allow more complex analyses with minimal training; and (7) continue our education and outreach
efforts. In addition to user-surveys, we will establish both user and technology expertise advisory boards to
provide feedback and guide development.
Diverse expertise is required for the efficient operation and development of the gEAR bioinformatics
platform. Our multi-disciplinary team members are a surgeon-scientist (PI), bioinformaticians (Co-Is), biologists
and engineers. Our experience in turning the gEAR from an abstract idea to a successful platform, widely
adapted in the ear field, and with multiple successful clones including NeMO Analytics (nemoanalytics.org) for
the BRAIN initiative should attest to our experience, expertise, and ability to deliver. Completion of the
proposed gEAR advancements will boost fulfillment of the great promises expected from omics data
generation and analyses and foster reuse of existing data, thereby catalyzing both basic science discovery and
advance development and translation of therapeutics for hearing and balance disorders.

Public health relevance
PROJECT NARRATIVE The gene Expression Analysis Resource (gEAR portal, umgear.org) is a cloud-based tool for analysis, visualization and sharing of multi-species multi-omic inner-ear related data. It serves to bridge the gap between the breadth, depth and complexity of high throughput multi-modality omics data and the biologists, which are often not trained in programming, yet require meaningful and rapid access to these data for their work. Completion of the proposed gEAR advancements will catalyze basic science discovery and advance development of therapeutics for hearing and balance disorders.